Iowa StARR Scholars Program

PROJECT SUMMARY
The Iowa StARR Scholars Program is designed to help address the continuing need for physician-scientists in
the fields of internal medicine and pediatrics. The University of Iowa Carver College of Medicine (CCOM) has an
outstanding group of physician-scientists, a tradition of training physician-scientists, and a long history of
physician-scientist leadership. The Iowa StARR Scholars Program will identify residents early in their training
who have an interest in a mentored research experience during their residency. The Specific Aims of the
program include: Aim 1. To recruit and train outstanding Scholars from the University of Iowa internal
medicine and pediatric residency programs to increase the pipeline of physician-scientists. Aim 2. To create
an academic environment that stimulates and encourages promising trainees toward a career path as a
physician-scientist. Aim 3. To provide a highly focused and mentored research experience in the areas of
cardiovascular, lung, blood, and sleep diseases that promotes the Scholar’s success. Aim 4. To develop a
personalized mentoring and career development plan for each StARR Scholar that ensures mastery of
clinical skills and outstanding training and development as a scientist. Aim 5. To provide guidance and advice
for subsequent subspecialty fellowship training. We will focus on trainees who may not have otherwise
considered a career as a physician-scientist, and will provide them with the opportunities, mentoring, and skills
they need to succeed. This will be accomplished through a positive mentored research experience over 12-18
months in the context of their residency. Subsequent to this program, we anticipate that trainees will pursue
subspecialty training with a research focus and pursue research-oriented independent careers in academic
medical centers. We identified a team of outstanding, diverse, accomplished mentors in basic, translational, and
clinical research responsive to NHLBI priorities. The Iowa StARR Scholars Program will provide an environment
conducive to success. Key features include: 1) a mentored research experience that promotes the Scholars’
success and enthusiasm for a career as a physician-scientist. This includes immersion in a rich research
environment with interactions with successful physician-scientists; 2) an individual development plan designed
around the trainee’s experience and career goals and supervised by a mentoring committee; 3) regular
assessment of research competencies; 4) training in forms of communication including slide preparation,
planning of scientific talks, presentations at regional and national meetings, and manuscript writing and
publication; 5) a range of program activities including selected coursework, conferences and symposia, designed
to enrich the research experience and provide context for future success. At the completion of the program Iowa
StARR Scholars should have the clinical and research backgrounds needed to attain board eligibility in pediatrics
or internal medicine, succeed in subspecialty training, pursue support via the K38 program, and advance to
faculty positions aimed at independent research careers.

Public health relevance
PROJECT NARRATIVE The goal of this application is to identify and encourage trainees in internal medicine and pediatrics to pursue a mentored research experience during their residencies as a means to address the critical shortage of physician- scientists in the United States. Our mentored research training program leverages the acknowledged strengths in cardiovascular, pulmonary, hematology, and sleep research at the University of Iowa. At the completion of training, Scholars should have the clinical and research backgrounds needed to attain board eligibility in pediatrics or internal medicine, succeed in subspecialty training, and advance to faculty positions aimed at independent research careers.